Exercise Pressor Reflex in Peripheral Artery Disease: Roles of Flow Limitation and Reperfusion

PROJECT SUMMARY/ABSTRACT
Our goal is to identify the mechanisms responsible for cardiovascular disability in peripheral artery disease (PAD)
and to then examine therapies that will reduce the impact of these pathophysiologic processes. We have
demonstrated that the exercise pressor reflex (EPR) during leg exercise is exaggerated in PAD patients. The
mechanisms for the exaggerated EPR in PAD patients have not been examined thoroughly. Utilizing both human
and animal studies, we propose to examine the roles of blood flow restriction (BFR) and ischemia-reperfusion
(IR) stress in inducing the exaggerated EPR. We anticipate that a blockade of acid sensing ion channels (ASICs)
with amiloride will reduce the exaggerated EPR and enhance the walking tolerance in PAD patients. Aim 1:
Determine the role of BFR in inducing the exaggerated EPR in PAD. We hypothesize that BFR leads to a
greater H+/lower pH in the interstitium of exercising muscles and thereby accentuates the EPR via stimulating
ASICs. We propose to employ BFR in healthy subjects to simulate the BFR in PAD. We speculate that BFR will
augment the EPR in the placebo trial and amiloride will reduce the EPR and increase exercise time/load under
BFR condition. We also speculate that amiloride will play the same beneficial role in PAD patients. In animal
studies, we speculate that BFR by femoral artery occlusion will increase interstitial H+/decrease pH thereby
exaggerating the EPR via ASIC subtype 3 (ASIC3) and prolonged occlusion will upregulate ASIC3 expression
in muscle afferent nerves of PAD. Aim 2: Determine the role of IR in inducing the exaggerated EPR in PAD.
We hypothesize that IR contributes to the exaggerated EPR in PAD and amiloride reduces the exaggerated EPR
induced by IR stress via blocking ASICs. Healthy subjects will perform plantar flexion exercise under free flow
conditions and after 20 min ischemia followed by 20 min reperfusion. We speculate that IR stress will accentuate
the EPR. PAD patients before and after leg revascularization will also perform plantar flexion exercise. We
speculate that amiloride will improve the EPR and increase exercise time/load in subjects after IR stress and in
PAD patients with revascularization. In animal studies, we will examine the EPR in IR rats at different time
courses and speculate that in IR rats satisfied reperfusion will alleviate the EPR and the pressor response
induced by activation of afferent nerves’ ASIC3. Aim 3: Determine the effects of ASIC on exercise ability in
PAD and fundamental mechanisms. We speculate that amiloride will decrease the pressor response to
walking and increase the claudication onset time and walking distance/time in PAD patients. In animal studies,
we speculate that exaggerated EPR induced by the IR will be attenuated in ASIC3 knockout rats. We will
compare the protein levels of ASIC3 and its current response in muscle afferent neurons between IR rats at
different time courses and their counterparts serving as controls. We speculate that ASIC3 expression and its
current response in muscle afferent neurons will be amplified during the initiating IR stage and the effects of IR
will be reduced by ASIC3 knockout or with sufficient time of reperfusion.

Public health relevance
PROJECT NARRATIVE Peripheral artery disease (PAD) is atherosclerotic disease with a blood flow obstruction to the lower extremities. Supervised exercise is commonly recommended for PAD patients whereas an exaggerated blood pressure response during exercise is a risk factor for cardiovascular diseases. This grant is to examine the role played by amiloride in improving the exaggerated sympathetic and blood pressure responses to exercise in PAD and further study the cellular mechanisms by which amiloride has beneficial effects, providing a potential base for better improving the blood flow directed to the ischemic limbs and enhancing walking ability in PAD patients.